3D Cellular and Molecular Mapping within Skeletal Tissue

The goal of the HuBMAP program is to build high resolution 3-D molecular maps of tissues at the subcellular level including spatial gene expression analysis of transcriptional activity. To date the representative tissues have not included the mineralized skeletal system due to technical issues that preclude the requirements of the HuBMAP program. We have solved those issues with a protocol that is capable of performing multimodal histology that include methods for advanced and repetitive in situ hybridization for both RNA and protein targets, known as MERFISH and CODEX, respectively. In this pilot project, we will develop this technology for the bone and cartilage structures of the knee. There are three divisions of effort led by separate directors. The Coordination Component will acquire de- identified human distal femur samples from the National Disease Research Interchange. A series of core biopsies will be extracted from the articular and enthenic cartilage, oriented to its source location, imaged by µCT to capture its mineral structure and processed into a histological stack to create a 3D representation of the tissue. Using the histological stack, the Mineralized Tissue Component will perform both MERFISH in situ hybridization and immunohistology using bar coded antibodies to identify multiple cell types. The Data Analysis Component will translate the image files generated by these techniques into 3D cellular maps of the target tissue of each cell type. From those data files, our contextual molecular mapping program, TOPAS, will identify the 3D relationship of cells within the cartilage, osteoblast and osteoclast lineages. Essential to the objectives underlined above, we need to assemble and implement a high throughput microscope system capable of performing MERFISH or CODEX types of experiments in which a computer automation script coordinates cycles of hybridization and washes with a microscope which scans, images and tiles specific regions of tissue. This supplement request funds to cover cost of this instrumentation. Our long-term goal, once the pilot program affirms the validity of our experimental platform for the knee, is to expand its use to a broad range of skeletal tissues and more complex cellular targets as a new investigatory resource to interrogate the major genetic and therapeutic challenges affecting skeletal health.

Public health relevance
The supplemental request will be directed toward the assembly of a computer-controlled fluorescence scanning microscope linked to a multi-channel fluidics system required for imaging gene and protein signals emanating from single cells within a human skeletal tissue. It will be capable of performing the histological techniques called MERFISH and CODEX.